Optimization and preclinical characterization of anthranilamide derivatives for Alzheimer prevention

Alzheimer's disease (AD) is a devastating dementia without a disease-modifying therapy. According to
FDA, AD clinical trials are over 200 but so far have made zero success in slowing AD progression. This continuous
failure speaks for the difficulty of this task and calls for re-evaluating the existing therapeutic strategies.
As a neurodegenerative disorder, neuronal death is fundamental to AD pathogenesis. Current therapeutic
strategies concentrate on combating neurotoxic insults implicated in AD (i.e., Aβ, phospho-tau, free radicals,
inflammatory toxins, etc.). Less attention has been paid to strengthening neuronal defense given that neuronal
death is an imbalance between its defense and insult. Studies in our lab revealed that defense mechanism of
central cholinergic system in AD is compromised in subjects with G protein-coupled receptor (GPCR) kinase-5
(GRK5) deficiency; the latter appears during aging and worsens in AD. The compromised neuronal defense leads
to susceptibility to degeneration triggered by excessive Aβ or hypoxia whereas an active anthranilamide
derivative CN168 was able to prevent the neurodegeneration and the cognitive impairments in GRK5-deficient
Swedish APP transgenic (GAP) mice. Therefore, emerging evidence supports the idea that strengthening
neuronal defense raises neuronal death threshold thus increasing the difficulty for various neurotoxic insults to
trigger neuronal death. This new therapeutic strategy focuses on the defense rather than individual insult but
works against multiple insults simultaneously. Such a therapeutic effort will not replace, but rather complement,
the existing therapeutic effort, therefore bringing new hope for discovering disease-modifying therapy for AD.
While CN168 was proven to be effective at the level of proof-of-concept (PoC) in preventing cognitive
decline in GAP mice, we also noticed that CN168 has two violations of the five drug-likeness rules (MW>500;
LogP>5), with a short duration of central action. This requires further optimization of the pharmacokinetic (PK)
properties of CN168 prior to future clinical studies. Because CN168 has proven in vivo efficacy and previously
demonstrated superb selectivity and sensitivity towards muscarinic receptor-2, we propose to use CN168 as the
active pharmaceutical ingredient (API) and to improve its brain to plasma (B2P) ratio using prodrug approach.
In this project, we will characterize three carefully selected prodrugs of CN168 by comparing their PK properties,
and study their pharmacodynamics (PD) and toxicology before preparing the investigational new drug (IND)
application for the finally selected prodrug(s). We will achieve our goals with the following three Specific Aims:
Aim 1. Pharmacokinetics of the API (CN168) and its prodrugs: in this aim we will (1) synthesize
CN168 and its prodrugs in quantities sufficient for their PK profiling in vivo; and then (2) carry out their PK
characterization and select the prodrug(s) outperforming CN168 with improved B2P ratios.
Aim 2: Pharmacodynamics and toxicology of the selected CN168 prodrugs: in this aim, we
will perform (1) PD studies for target engagement verification, effective dose range finding, and evaluation of
potential side effects in GRK5-deifienct mice along with wild type mice; and (2) Drug toxicity studies, including
in vitro and in vivo acute toxicity, and repeated dosing toxicity and long-term (9 months) toxicity.
Aim 3: Drug cGMP manufacturing and IND application: In this aim, we will (1) manufacture the
final prodrugs domestically in the US at a cGMP facility; and (2) prepare for the IND application to FDA.
AD is the most persistent and devastating dementia worldwide. Yet the clinical trials aimed at finding a
disease-modifying therapy for AD have failed one after another. Through decades of research on GRK5 deficiency
in AD we came up a new therapeutic strategy that is distinct from, but may complement with, the existing
therapeutic efforts that focus on individual insult. We have obtained PoC evidence with the API CN168. Further
improvement of its PK properties will ensure its success at preclinical stage and ease its way towards a successful
translation to future clinical trial. We believe this is a chance to develop a disease-modifying therapy for AD.

Public health relevance
Alzheimer's disease (AD) patients and some normal elderly appear to have deficiency of a molecule called GRK5, which is an important protein regulating many physiological processes, including memory. Low levels of GRK5 will make the neurons participating in memory function more susceptible to cell death. In this project, we propose to characterize and optimize an active pharmaceutic ingredient CN168 with already demonstrated proof-of-concept efficacy in preventing cognitive decline in GRK5-deficient mice. We will synthesize CN168 and its prodrugs and test them in animals to select the best prodrug candidates based on their pharmacokinetic properties. The selected prodrug(s) will then be tested again in the GRK5-deficient and normal animal models and make sure they are effective and safe to use before submitting an investigational new drug approval through the Food and Drug Administration.